Data Management and Statistical Core

PROJECT SUMMARY – Data Management and Statistics Core (DMSC)
The overall objective of the Data Management and Statistics Core (DMSC) is to provide a unified and
integrative framework for data management, statistical support, and mentoring to enhance the UC Davis
Alzheimer’s Disease Research Center (UCD ADRC) goals. To support the goals of the UCD ADRC, the DMSC
will focus on four specific aims: 1) continue modernizing our data management system using a secure and
dynamic web-based interface and integrate processes with other ADRC cores emphasizing data collection,
data management, creation of study reports, and a data-sharing portal; 2) provide project development and
analysis support to ADRC investigators and other AD researchers through standard and innovative statistical
methods; 3) develop and implement multiple biomarkers approaches for pathogenesis using data across
ADRC cores; and 4) in collaboration with the Research Education Component, mentor the next generation of
researchers on biostatistical methods and study design. The DMSC brings together a qualified team with
expertise in data management, analysis of longitudinal and neuroimaging data, and the conduct of and
integration with epidemiology studies and mentoring of junior research faculties across the UC Davis and AD
research communities. The DMSC serves a central integrative function for the ADRC, including a web-based
data management system that allows de-identified access to current data, and administrative, tracking, and
summary reports. Expertise provided by the DMSC leaders enables the use of sophisticated statistical
approaches with high impact scientific discoveries. The DMSC will provide innovative solutions for data
integration across all UCD ADRC cores and provide standard and novel statistical approaches for
disseminating the complicated relationship between risk factors and long-term cognitive decline and dementia
progression in diverse populations. The DMSC will also continue to lead in mentoring and training graduate
students, postdocs, and junior faculties and collaborate with AD researchers nationally and internationally.